NMR STUDY OF LITHIUM INTERACTIONS IN ERYTHROCYTES

The main goal of this investigation is to advance the understanding of the biological action of lithium by analyzing the binding and transport properties of the Li+ion in human red blood cells (RBCs) by nuclear magnetic resonance (NMR) spectroscopy. Although a great deal of effort has gone into testing the validity of Li+ transport rates and ratios as genetic markers of bipolar disorders, very little attention has been given to the investigation of Li+ interactions in tissues. We propose to investigate at a molecular level how the Li+ ion changes ion binding and membrane dynamics in control RBCs and then establish whether Li+ has the same or a different effect in RBCs from bipolar patients undergoing lithium treatment. The proposed non-invasive NMR methods will test two possible mechanisms of action of lithium: a membrane abnormality hypothesis, and a competitive mechanism between Li+ and Mg2+ for biological ligands. Our preliminary studies indicate that the NMR methods proposed in this study provide new information about Li+ interactions in RBCs. For example, Li+ binding to membrane components in control RBCs and competition between Li+ and Mg2+ for ATP binding sites can be monitored by the proposed methods. Li+ perturbations of ion transport and binding in RBCs may not be directly applicable to brain tissue, which is the site of Li+'s action in bipolar patients. However, Li+ is administrated orally and thus a detailed knowledge of its interaction with blood components is essential for understanding the known toxicity of this drug. The proposed studies will also contribute to a useful and important database of Li+ interactions in RBCs. Moreover, the results of this research will be of a general interest to those investigating biological transport.